Neuroprotection of Remotely Administered Hypothermia on Spleen in Ischemic Stroke

In spite of decades of research, stroke therapies are limited to recanalization therapies that can only be
used on < 10% of stroke patients; the vast majority of stroke patients cannot be treated by these methods. Even
if recanalization is successful, the outcome is often poor due to subsequent reperfusion injury. A major damage
mechanism operating in stroke is inflammatory injury due to excessive pro-inflammatory cascades. Our long-
term research goal is to develop effective neuroprotection strategies to lengthen the therapeutic window and
prevent brain damage after reperfusion. We propose here a novel, high risk/high reward approach of Remotely
Administered Hypothermia (RAH) to mitigate inflammatory injury by inducing spleen hypothermia to suppress
pro-inflammatory mediators in the acute phase of stroke, and thereby reduce brain injury and improve functional
outcomes.
Many studies have shown that, after stroke, splenic inflammatory cells, including neutrophils,
monocytes/macrophages, and lymphocytes, are released and infiltrate the brain, heightening brain inflammation
and exacerbating ischemia/reperfusion injury. Clinical studies have observed spleen contraction in acute stroke
patients where functional outcome improved with the gradual recovery of spleen volume. These observations
are supported by stroke animal studies showing spleen volume decrease during the acute phase of middle
cerebral artery occlusion (MCAO), and transfer of splenocytes to stroke-injured brain areas. Activation and
release of splenic cells is upstream of excessive brain inflammation in stroke. Therefore, regulation of splenic
activity offers a therapeutic target for decreasing brain inflammation and improving stroke outcomes . Animal
studies however, often use irreversible manipulations of the spleen, such as splenectomy or radiation-induced
inhibition of spleen function, which clearly are not clinically practical.
Here we use the rat MCAO model to investigate our novel approach to reversibly suppresses spleen
inflammatory activity in the acute phase of stroke by administering spleen hypothermia to mitigate excessive
brain inflammation. The powerful neuroprotective effect of hypothermia has long been recognized in focal
ischemic stroke. However, the clinical use of whole-body hypothermia is limited due to adverse side effects. Our
novel RAH of spleen does not have these adverse side effects and is effective at decreasing brain inflammation,
reducing infarct volume, and improving functional outcomes. This high risk/high reward approach, in which
contemporaneous in situ reperfusion and remote administration of neuroprotective therapy (spleen hypothermia)
is readily clinically translatable. Successful completion of the proposed studies will lay the foundation for treating
stroke patients with a reversible inhibition of proinflammatory spleen function that will preserve the positive
benefits of spleen function in the post-acute phase of stroke.

Public health relevance
Over one hundred stroke clinical trials have failed to generate a clinically effective neuroprotective treatment, and FDA-approved stroke treatments can be only used on less than 10% of stroke patients. In this proposal we offer the novel theory that the spleen, an important immune system organ, can be manipulated to protect the brain during stroke. We propose to investigate a novel, high risk/high reward technique, Remote Administration of Hypothermia (RAH), that reversibly cools the spleen during the acute phase of stroke to suppress its inflammatory activation, and thereby decrease stroke-induced brain inflammation, which will ultimately limit stroke damage and improve functional outcomes.